Toward understanding the role of altered glycosylation in cancer

Project Summary
Altered glycosylation is concomitant with malignant transformation, but the functional significance with regard to
cancer progression is not well understood. This gap in knowledge is largely attributable to the difficulties
associated with studying cell-surface glycoproteins. Thus, it is imperative to understand how dysregulated
glycosylation contributes to immune evasion, and to develop methods that allow for facile probing of glycan
changes in cancer. We seek to attain these goals with an interdisciplinary approach combining glycoproteomics,
biochemistry, bioinformatics, and spatial visualization of glycans.
First, glycosylation contributes to important immune signaling events within the tumor microenvironment. For
instance, T cell immunoglobulin and mucin-domain containing 3 (TIM3) is an emerging checkpoint inhibitor
currently under investigation for cancer immunotherapy. TIM3 is a glycosylated mucin glycoprotein, with at least
10 predicted glycosites. However, very little is known regarding TIM3 glycosylation or its effects on protein
function, ligand binding, and immune signaling. One ligand of TIM3, galectin-9 (Gal-9), is known to bind glycans
on TIM3 resulting in downregulation of T cell activation. The particular glycan structure and/or glycosite targeted
by Gal-9 is currently unknown. Thus, in Project 1, we will probe the glycoepitope key to the Gal-9/TIM3 axis by
combining intact glycoproteomics and glycome engineering with biochemical and immunological assays.
In Project 2, our goal is to develop methods for visualization of O-glycan spatial distribution. Currently, the
premier method to spatially examine N-glycans is MALDI mass spectrometry imaging (MSI), wherein N-glycans
are removed enzymatically and imaged; however, no homologous enzyme is known for O-glycans. We will
overcome this issue by using a combination of proteases selective for O-glycosylation, referred to as O-
glycoproteases or mucinases. Additionally, we will perform on-tissue microscale glycoproteomics, which will
allow us to couple the O-glycan MSI information with the associated glycoproteins. Together, these experiments
will provide spatial resolution of dysregulated O-glycans and their underlying proteins.
Finally, one of the most significant challenges currently facing the glycoproteomic field is the dearth of accurate
and reliable methods for data processing. In Project 3 we seek to address this disparity by first comparing
currently existing software algorithms with regard to speed, accuracy, user interface, and scoring. Our long-term
goal, though, is to create a novel interface that takes advantage of my laboratory’s extensive experience with
manual validation, de novo sequencing, and C# programming. Our program will include methods used inr de
novo sequencing while accommodating multiple types of glycans, chemical modifications, and MALDI MSI data.
Ultimately, upon attaining the goals of this proposal, the methods and insights we develop will prove invaluable
to the fields of mass spectrometry, glycoproteomics, and MALDI MSI. Additionally, the biological information
gathered will shed light on how glycosylation contributes to tumor progression.

Public health relevance
Project Narrative Aberrant glycosylation is a hallmark of cancer and contributes to the ability of transformed cells to escape immune surveillance and proliferate uncontrollably. However, mechanisms underlying these processes are not well understood, in part because glycosylation is exceptionally difficult to study. To bridge this disparity, we strive to understand how glycosylation contributes to downregulation of immune signaling, how altered glycans vary spatially within and around tumors, and how data processing can be streamlined in glycoproteomic experiments. .